University of Kentucky SuRE Resource Center

SUMMARY
The overarching goal of the University of Kentucky SuRE Resource Center (UK-SuRE), supported by an
NIGMS U24 grant, is to assist faculty and Office of Sponsored Project (OSP) staff at SuRE-eligible
institutions (<$6 million in NIH funding, >25% PELL eligible students) prepare and submit competitive NIH
grants applications, with an emphasis on SuRE and SuRE-First awards. To accomplish this goal, UK faculty
and research support staff with experience in all aspects of NIH grant applications will share their
knowledge with those at SuRE-eligible institutions through a series of webinars, workshops, and direct
consultation. Three regional coordinators will provide vital links between faculty and OSP staff at SuRE-
eligible institutions and faculty and research support staff at UK-SuRE. This center will also coordinate
biennial SuRE Conferences and oversee a competitive seed grant program that will provide funds for
SuRE-eligible institutions to establish or grow OSPs. Specifically, four aims are proposed: (1) Assist SuRE-
eligible faculty write grants and manage research programs, with success being measured by number of
grants submitted, scored, and funded; number of publications, seminars; and meeting presentations; and
tenure and promotion outcomes; (2) Assist SuRE-eligible institutions to establish and grow OSPs and
research infrastructure, with success being measured by growth/establishment of OSPs in SuRE-eligible
institutions, number of research grants received and overall research funding at these institutions, and
questionnaires for SuRE faculty regarding the quality of in-house OSP services; (3) Grow the number of
institutions that participate in the SuRE Program and establish an interactive community of SuRE-eligible
institutions, with success being measured by the number of institutions that participate in webinars, attend
the biennial conference, and submit NIH grants (with an emphasis on SuRE applications), as well as the
amount of peer-to-peer faculty mentoring and social media engagement; and (4) Enhance the research
experience for students who are working in NIH-funded labs in SuRE-eligible institutions, with success
being measured by student conference presentations, authorship on publications, degrees earned, and
post-graduate employment. Taken together, these activities will enhance the research capacity at SuRE-
eligible institutions and promote high-quality, student-centric biomedical research. In the process, these
outcomes will contribute to diversifying and strengthening the nation’s research enterprise.

Public health relevance
NARRATIVE The overarching goal of the University of Kentucky (UK) SuRE Resource Center is to build research capacity at SuRE-eligible institutions, recognizing the vital contribution these colleges and universities make to the nation's research enterprise. Through a series of webinars and other training modalities, direct consultation, a competitive seed grant program to create or enhance offices of sponsor projects (OSPs), and biennial conferences, experienced UK faculty and research support staff will assist faculty and OSP staff at SuRE- eligible institutions prepare and submit competitive NIH grants applications, with an emphasis on SuRE and SuRE-First awards. Multiple methods will be used to collect and analyze data to measure the success of this center.